A Novel Presynaptic Role for MHCI in Regulating Cortical Synapse Formation

Project Summary
For years, researchers have observed evidence of cross–talk between the immune system and the nervous
system, but the idea that immune molecules play non-immune roles in the brain in the absence of disease has
only recently gained attention, due in large part to work focusing on the major histocompatibility complex I
(MHCI) molecules. In the central nervous system, MHCI is expressed in neurons and glial cells and regulates
many aspects of development, including activity-dependent synaptic refinement, and synaptic and homeostatic
plasticity. MHCI has also been implicated in mediating both genetic and environmental risk factors of a wide
range of brain diseases, including autism and schizophrenia. In addition to its well-documented roles in
plasticity and disease, the McAllister laboratory recently demonstrated that MHCI molecules on neurons
negatively regulate the establishment and function of connections onto cortical neurons. MHCI in the
postsynaptic cell clearly mediates some of this effect, but MHCI is also present in axons and in the presynaptic
terminal and remarkably, there are no reports to date of any function for MHCI in these presynaptic
compartments. Using a novel co-culture system, I have discovered that MHCI levels in presynaptic neurons
negatively regulate the number of synapses they form onto their targets. The central goal of my thesis is to
determine whether, and how, MHCI molecules in presynaptic cortical neurons regulate the density of
synapses formed onto their targets. In Aim 1, I will determine whether specific types of MHCI molecules
(H2-Kb and H2-Db) in presynaptic neurons negatively regulate the density and dynamics of synapses those
neurons form with their targets in cortical cultures. Then, I will use a novel, innovative long-term imaging assay
to measure the effect of MHCI on synapse dynamics in order to start to determine how MHCI in presynaptic
neurons negatively regulates synapse development. In Aim 2, I will determine whether activity regulates the
density and dynamics of synapses a cell makes onto its targets, as well as whether the presynaptic effects of
MHCI on synapse density are activity-dependent. Results from this project will provide new information about
the protein dynamics underlying synapse formation and elimination in early developing neural networks and
will reveal novel cellular mechanisms mediating the effects of MHCI in neural development, including the first
role for presynaptic MHCI In regulating synapse formation. My findings may thereby provide insight into how
novel therapies could be developed to alter MHCI signaling in the brain in the future to ameliorate neuro-
immune-based disorders. These discoveries, together with the new techniques and career skills I will learn
through my training plan, will position me optimally for a successful future career in neuroimmunology
research.

Public health relevance
Project Narrative Although MHCI is present in axons and presynaptic terminals of developing neurons, the function of MHCI in these compartments is completely unknown. Here, using a novel co-culture assay and innovative long-term live imaging approaches, I will determine whether and how MHCI molecules in presynaptic neurons regulate synapse density and dynamics and whether this novel function is activity-dependent. Results from this project will reveal new functions for MHCI molecules in neural development, thereby providing critical insight into how they might contribute to the pathogenesis of neurodevelopmental disorders and identifying novel targets for future development of therapies aimed at altering MHCI signaling in the brain to ameliorate neuro-immune- based disorders.